INSULIN RESPONSE TO PROLONGED HYPERGLYCEMIA IN FIRST DEGREE RELATIVES

The specific aim of this project is to investigate whether beta cell adaptation to prolonged hyperglycemia is defective in glucose tolerant first degree relatives with non-insulin dependent diabetes mellitus (NIDDM) as compared with normal subject.